BLOOD PRESSURE REACTIVITY AND CORONARY HEART DISEASE INCIDENCE

Blood pressure reactivity, measured by the cold pressor test, was related to subsequent coronary heart disease and total mortality over 42 years of follow-up in 910 former Johns Hopkins medical students.